Statistical Analysis Methods and Software for ChIP-seq Data

DESCRIPTION (provided by applicant): The advent of high throughput next generation sequencing (NGS) technologies have revolutionized the fields of genetics and genomics by allowing rapid and inexpensive sequencing of billions of bases. Among the NGS applications, ChIP-seq (chromatin immunoprecipitation followed by NGS) is perhaps the most successful to date. ChIP-seq technology enables investigators to study genome-wide binding of transcription factors and mapping of epigenomic marks. Both of these play crucial roles in programming of gene expression in a cell specific manner; therefore their genome-wide mapping can significantly advance our ability to understand and diagnose human diseases. Although basic analysis tools for ChIP-seq data are rapidly increasing, all of the available methods share one or more of the following shortcomings. First, they focus on analyzing one ChIP- seq sample at a time. As ChIP-seq is becoming commonly utilized in epigenome mapping to understand phenotypic variation, the demand for methods that can handle multiple samples efficiently is rapidly rising. Second, they only utilize sequence reads that align to unique locations on the reference genome. This hinders the study of highly repetitive regions of genomes by ChIP-seq. Third, commonly used designs for ChIP-seq experiments employ one matching control sample per each ChIP-seq sample. This limits the genome coverage of control experiments and impacts the detection of enrichment in ChIP samples. It also significantly contributes to increase in sequencing costs for large-scale ChIP-seq studies. The objective of this project is to address these challenges of ChIP-seq analysis in three specific aims: (1) Statistical methods for inference from multiple samples; (2) Probabilistic models for utilizing reads that map to multiple locations (multi-reads) in the genome; (3) Development and evaluation of in silico pooling designs for control experiments. The projects will be accomplished through a combination of methodological development, simulation, computational analysis, and experimental validation. Methods will be developed and evaluated using datasets from the ENCODE, modENCODE, and the RoadMap Epigenomics consortiums as well as novel datasets from collaborators. Statistical resources generated from the project, which will be disseminated in publicly available software, will provide essential tools for the efficient design and analysis of ChIP-seq experiments.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed research is relevant to public health because capturing genome- wide binding of transcription factors and epigenomic information by ChIP-seq technology is invaluable for comprehensively understanding development, differentiation, and disease. ChIP-seq experiments present unprecedented challenges in statistical analysis. We will develop statistical methods and tools for challenging aspects of ChIP-seq analysis and disseminate results and software to the research community.